Evaluating and improving the efficacy of Extracorporeal Cardiopulmonary Resuscitation (ECPR) in pediatric patients using interactive Machine Learning

Project Summary/Abstract
Pediatric cardiac arrest is a serious life-threatening problem affecting more than 15,000 hospitalized children each
year in the US alone. Fewer than 50% of these children survive to hospital discharge, and neurological morbidity
is common among those who survive. Importantly, pediatric cardiac arrest survival outcomes plateaued more
than a decade ago, and there is hence a critical need for evidence-based and innovative therapeutic approaches.
In particular, a signiﬁcant number of patients fail to achieve return of spontaneous circulation (ROSC) even af-
ter 30 minutes of conventional CPR and may be candidates for what is termed Extracorporeal cardiopulmonary
resuscitation (ECPR). ECPR is a treatment that involves the use of veno-arterial extracorporeal membrane oxy-
genation (VA-ECMO) and has been used successfully for resuscitation from shock or cardiac arrest in adult and
pediatric patients. It is often utilized as an alternative resuscitation intervention for in-hospital Cardiac Arrest
(IHCA) patients. Currently it is not clear if and which subpopulation of cardiac arrest victims may beneﬁt from
this intervention. Hence this proposal aims to develop advanced machine learning and signal processing algo-
rithms using a sizeable, high-quality dataset which will identify speciﬁc underlying characteristics of the patient
who would beneﬁt from ECPR. In particular, in Aim 1, we will develop a model using pre-arrest demographic,
physiologic, and biochemical data to predict failure to achieve ROSC within 30 minutes of CPR. We will also de-
velop a model using pre-arrest and intra-arrest physiologic data, including continuous invasive and non-invasive
waveform data over the ﬁrst <5, <10, <15, <20, <30 minutes of CPR to predict failure to achieve ROSC. In Aim
2, we will identify pre- and intra-arrest characteristics from discontinuous data and continuous invasive and
non-invasive waveform data of ECPR and develop a model to predict survivability to hospital discharge. Such a
model would enable initiation of ECPR in critically ill patients who are unlikely to survive otherwise and hence
lead to overall improvement of survival for in-hospital CPR patients.

Public health relevance
Project narrative Cardiopulmonary Resuscitation (CPR) is a commonly performed procedure (more than 15,000 children in US alone) to resuscitate a stopped heart and the conventional procedure is not very effective especially for pediatric patients since less than 50% survive to discharge. The proposed research will use already collected data and develop a computational model to identify patients who are unlikely to survive with conventional CPR and can beneﬁt from a special procedure called ECPR that has been known to improve survival under certain circum- stances. The proposed research will provide a systematic and mathematically sound procedure to pick ECPR candidates and is expected to result in substantial improvement of survival rates for pediatric populations.